Disease Progression Modeling of Bladder Cancer

PROJECT SUMMARY/ABSTRACT
Carcinogenesis may be viewed as a multistep evolutionary process characterized by accumulation of
genetic and epigenetic alterations, driven by selective pressures imposed by the microenvironment. The
delineation of tumor evolution would provide invaluable insights into tumor biology and lay a foundation for
the development of improved diagnostics, prognostics and targeted therapeutics.
Time-series data are ideal for deriving models of dynamic progression, but this is impossible to collect in
human cancer because of the need for timely surgical intervention and systemic therapy, which alter the
natural history of the disease and exert selection pressures that affect tumor evolution. To overcome the
human serial sampling issue, we have devised a computational strategy to understand cancer evolution by
deriving pseudo time-series data from ‘static’ samples (excised tissue specimens). The design is based on
the rationale that each sample can provide a snapshot of the disease process, and if the number of samples
is sufficiently large we can recover a visualization of disease progression. We demonstrated the utility of the
developed pipeline - referred to as CancerMapp - by applying it to the analysis of gene expression data from
over 9,000 breast tissue samples. Breast cancer progression modeling identified 2 major trajectories to
malignancy – an early split to basal tumors, and a continuum through luminal tumors. The computational
approach and the breast cancer model concept have since been validated in independent studies, and our
findings have provided the impetus for a number of investigations at our institute and by colleagues in the
field.
Built logically on our previous work, we now propose a large-scale interdisciplinary research plan to derive a
progression model for bladder cancer (BLCA). BLCA is among the five most common malignancies
worldwide. In the US alone, new cases for 2018 are estimated at 72,500 with estimated deaths at over
15,000, figures that are anticipated to increase in the near future. Classification of BLCA into multiple
molecular subtypes has recently been proposed and has the potential to impact clinical management.
Nonetheless, significant biologic subgroup heterogeneity remains, and more work is needed before a unified
classification system can gain wide acceptance. More importantly, there is, as yet, no understanding of the
inter-relationships between subtypes. Insights into how subtypes are related and how cancer evolution
influences the observed changes in molecular pathologic phenotype is the next level of analysis required
and is the focus of this proposal.
The proposed work will inform a range of research directions that were previously unattainable. The
derivation of a BLCA roadmap and the identification of pivotal molecular events that drive stepwise cancer
progression will provide new insights into tumor biology and guide the development of improved cancer
diagnostics, prognostics and targeted therapeutics. Annotated progression maps can also guide the design
of clinical trials and animal studies to focus on pivotal points of cancer development, which may yield the
best return with limited resources.

Public health relevance
PROJECT NARRATIVE Human cancer is one of the leading causes of death worldwide, a reflection of the fact that the molecular basis of the disease is yet poorly understood. We propose to apply an advanced computational strategy to build a cancer progression model using genomic data obtained from excised tumor tissue samples (static data). The delineation of the dynamic processes involved, and the identification of pivotal molecular events that drive stepwise cancer progression will provide new insights into tumor biology and guide the development of improved cancer diagnostics, prognostics and targeted therapeutics. The over-arching goal of the project is to develop an annotated bladder cancer roadmap that can be used by ourselves and the research community to provide insights into the mechanisms and factors that drive bladder cancer to malignancy.